Developing RNP-MaP into a broad-spectrum toolset for discovery, definition, and drug targeting of RNA-protein complexes in live cells

ABSTRACT
My laboratory is interested in how interactions between RNA and RNA-binding proteins drive diverse biology and
disease, and how these RNA-protein complexes might be targeted to alter their functions. Existing knowledge
includes only a small fraction of protein-RNA interactions in the cell, and we know particularly little of how RNA-
binding proteins cooperate to form complexes on noncoding RNAs, which make up the vast majority of human
transcripts. Further, while pipelines for identifying protein-binding molecules for therapeutic development are
informed by significant understanding of protein structure, there is no existing equivalent for designing small
molecules that target RNA and RNA-binding interfaces. Critically, there remains a lack of straightforward
technologies for discovery, definition, and drug targeting of protein-RNA interactions inside cells.
To illuminate features of RNA-protein complexes and discover new ways to control their functions, my laboratory
is developing a suite of novel live-cell chemical probing technologies based around my unique RNP-MaP
approach (RNA-protein networks analyzed by mutational profiling). By enhancing and modularly extending the
base RNP-MaP framework, we will develop new facile methods for 1) mapping multi-protein networks on RNA
across transcriptomes and identifying associated RNA-binding proteins, 2) mapping transcriptome-wide targets
of RNA-binding proteins while simultaneously measuring RNA site-specific occupancy, and 3) mapping small
molecule RNA-targeting potential inside cells.
Our ultimate goal is to create a set of tools that could enable any medical research laboratory to identify,
characterize, and target any RNA-protein interface relevant to their disease/pathway/model of interest. By
providing the means to probe the uncharted landscapes of RNA-protein networks, this work will be foundational
for expansive new RNA biology discoveries and RNA-targeted therapeutics.

Public health relevance
PROJECT NARRATIVE Ribonucleic acid (RNA)-protein complexes are integral for every step of gene regulation in the cell, and noncoding RNA-protein complexes especially represent a large unexplored landscape of novel biology and potential therapeutic targets. We have a limited understanding of the contexts – nucleotide sequence, structure, and interaction networks – that determine how and where proteins assemble on RNAs in the cell, and how these complexes might be targeted by small molecules for therapeutic benefit. This proposal describes multiple technological advances in chemical probing and sequencing that will in the long term create a new encyclopedia of RNA-protein network elements, supporting new fundamental discoveries and highlighting the therapeutic potential of noncoding RNA-protein complexes.